Defining macrophage defense during Klebsiella pneumoniae bacteremia

Sepsis is defined as organ dysfunction resulting from dysregulated host response and is a both a leading
cause of global mortality and the most expensive hospital treated condition. Gram-negative species underly
about half of all bloodstream infections, thus bacteremia pathology is critical to understand. K. pneumoniae
(Kp) is the second leading cause of Gram-negative bacteremia and a leading cause of health-care associated
infections. The pathogenesis of Gram-negative bacteremia involves three phases: 1) initial site infection, 2)
dissemination to the bloodstream, and 3) survival in blood filtering organs. Kp fitness in the lung, a common
initial site of infection, has been studied but last phase of Kp-bacteremia is largely unexplored. There is a
fundamental gap in our understanding of how Kp perpetuates infection in the blood and filtering organs.
Macrophages have differing interactions with Kp across organs that correlates to overall Kp abundance within
tissues during infection. However, the relationship between macrophages and Kp is poorly understood. The
objective of this proposal is to define mechanisms of Kp restriction across distinct macrophage subsets
relevant to bacteremia. The central hypothesis is that tissue-resident macrophages provide distinct niches that
restrict or permit Kp in a manner dependent on bacterial initiation of cell death. I will test this hypothesis
through three specific aims: 1) define splenic macrophage restriction of Kp during bacteremia, 2) define host
pathways of Kp restriction by macrophages, and 3) discover Kp mechanisms of resistance to macrophage-
mediated killing through initiation of cell death pathways. This work is innovative as it will harness CRISPR-
genomic screening to study Kp pathogenesis and use existing transposon sequencing data to identify bacterial
factors that are required for resistance to macrophage killing. Findings from these approaches will be applied
to splenic macrophages, an immune cell subset rarely studied in Gram-negative disease. The research in this
proposal will support sustained positive impact through identifying both host and pathogen factors required for
unique tissue-specific responses across sites in bacteremia. This proposal is supported by a comprehensive
training plan which will support the development of technical and conceptual skills to investigate host-pathogen
interactions across tissue-resident immune cells during Gram-negative bacteremia. The skills gained with this
training plan could be applied to multiple organ sites and Gram-negative pathogens. This training will occur at
the University of Michigan with a team of mentors dedicated to the success of this proposal. The candidate's
background in innate immunology and bacteriology will be unified by mentors with expertise in host-pathogen
interactions, macrophage biology, CRISPR-genomics, bacterial genetics, and spleen biology. Together, the
expertise of the mentors and the research in this proposal will facilitate independence of the candidate. This
research will reveal tissue-specific interactions between macrophages and Kp during bacteremia.

Public health relevance
Project Narrative Klebsiella pneumoniae bacteremia can initiate sepsis, a leading cause of global morbidity that causes immense socioeconomic burdens as the most expensive hospital treated condition. This research will define host- pathogen interactions during K. pneumoniae bacteremia, with the goal of identifying pathways that can be targeted or enhanced by future therapies to aid in the clearance of bacteremia. By defining immunomodulatory processes of K. pneumoniae bacteremia that could result in novel therapies, this research directly advances the NIH mission of defining the nature and behavior of living systems to enhance health, lengthen life, and reduce illness and disability.